Impact of Blood Viscosity and Vascular Compliance on Fontan Circulation Dysfunction in Children

PROJECT SUMMARY/ABSTRACT
The Fontan surgical procedure has greatly improved survival in children born with univentricular congenital heart
defects. Unfortunately, most will develop multiorgan dysfunction, and all face a progressively increasing risk of
Fontan failure and premature death. Due to an incomplete understanding of the pathophysiology, Fontan failure
remains difficult to predict and treat. While the surgery creates the same fundamentally abnormal circulation and
vascular dysfunction in all patients by redirecting low-shear systemic venous blood from the heart to the lungs,
the variability in timing and presentation of Fontan failure is unexplained. Computational fluid dynamic (CFD)
modeling has been used to demonstrate that power loss across the Fontan conduit and pulmonary vasculature
is a significant but incomplete determinant of circulation performance. Although power loss is due to viscous
energy loss from shear forces in blood, prior studies have overlooked several important features of blood
viscosity, most notably its property of increasing exponentially at low shear rates (“non-Newtonian behavior”
[NNB]), such as in the Fontan circulation. The objectives of this project are to (i) elucidate the extent to which
NNB affects Fontan circulation performance in vivo; and (ii) correlate performance metrics with clinical markers
of Fontan failure. Based on published and preliminary in vitro observations, the central hypothesis is that patient-
specific variation in the NNB of blood, modulated by vascular compliance and cardiac output, determines Fontan
circulatory performance and clinical outcomes. The rationale for this proposal is that characterization of the role
of non-Newtonian viscosity in Fontan circulation pathophysiology will serve as a framework for developing
sensitive tools to screen for Fontan failure and pharmacologic therapies to prevent Fontan failure. This proposal
will harness the strengths of a multidisciplinary team from Children’s Hospital Los Angeles, University of
Southern California, University of California - Irvine, and University of Wisconsin. Using a combination of CFD
modeling, 4D flow magnetic resonance imaging, blood viscosity analysis, and exercise testing to study an
ethnically diverse cross-sectional cohort of pediatric Fontan patients, the central hypothesis will be tested by
pursuing these specific aims: (1) Determine the extent to which patient-specific differences in NNB explain
variability in Fontan circulation performance; (2) Determine the extent to which regional vascular compliance
modulates NNB; and (3) Determine the predictive value of non-Newtonian power loss on exercise capacity. The
K23 mechanism will allow the PI to complete a robust career development plan including formalized curricula in
study design, statistics, and engineering, and hands-on training in CFD modeling and 4D flow MRI. Together,
the research plan and career development activities will support the PI’s long-term goal of becoming an
independently funded physician-scientist, focusing on studying vascular biomechanics in children with congenital
heart disease in order to improve the diagnosis and management of cardiac decompensation.

Public health relevance
PROJECT NARRATIVE Although the Fontan surgical procedure, which reroutes blood from the heart to the lungs, has greatly improved survival in children born with “single ventricle” congenital heart defects, these patients remain at risk for significant organ dysfunction and premature death. The proposed research focuses on using magnetic resonance imaging and computational models to characterize the novel role of blood viscosity in the Fontan circulation, with the long-term goals of developing sensitive tools to screen for Fontan failure and therapies to improve care in this growing population of chronically ill patients. This project is relevant to public health and in line with the NHLBI’s mission as it will promote the prevention and treatment of heart disease, so that people with the Fontan circulation can live longer and have more fulfilling lives.